Development of Investigators Supporting Community Outreach and Value of Engagement in health disparities Research (DISCOVER)

PROJECT SUMMARY – Administrative Core
The Administrative Core (AC) of the DISCOVER Center of Excellence embodies core principles
essential for achieving its mission to promote health equity and address health disparities –
scientific leadership, strategic direction, collaboration and synergy, and career development.
Serving as the central hub that coordinates the activities of the various Cores within the center,
the AC undertakes several critical functions. The AC exercises administrative oversight over all
aspects of DISCOVER by providing strategic direction across the center, ensuring efficient
coordination and seamless interaction between the Cores, and working to maximize their
collective impact. The AC oversees information exchange between Cores, stakeholders, and
community members through a well-structured Communication Plan, involving a user-friendly
website, newsletters, and regular updates. By fostering collaboration and synergistic interactions,
the AC ensures seamless cooperation among investigators and mentors, creating a supportive
environment for all. The AC aims to: Aim 1. Design and implement an effective governance
structure to manage and coordinate the work across DISCOVER Cores. We will: a) Organize
DISCOVER’s External, Internal, and Community Advisory Boards, the Executive Committee, and
Core Leadership structure and meeting schedules; b) implement internal and external
communication strategies to promote collaboration and efficiency across the work of each core;
and c) oversee management and tracking of DISCOVER reporting. Aim 2. Administer pilot
funding and track and evaluate research and professional development outcomes among
DISCOVER investigators. We will: a) provide pilot funding and oversee administrative aspects
of the call for proposals and review process, b) provide oversight of mentor lists and completion
of CIMER mentor training, and c) track and evaluate DISCOVER investigators’ progress on pilot
research, scientific productivity, and professional development outcomes. Aim 3. Communicate
DISCOVER training activities and investigators’ research progress and career
accomplishments. We will: a) promote DISCOVER training, career development, and pilot
funding opportunities to reach a broad group of early career investigators across GUMC, and b)
showcase investigators’ scientific and career accomplishments through an Annual Research
Retreat and communication with the research community.